Core 5 - Biostatistics and Bioinformatics Core

Project Summary – Core 5 – Biostatistics and Bioinformatics Core Dana-Farber Cancer Institute
Studies from the previous grant period confirmed that achieving MRD negative status provides significantly
superior progression free and overall survival outcome. Moreover, the studies by IFM have shown that high dose
chemotherapy followed by autologous stem cell transplant (HDT) provide significant PFS benefit. With the help
of this Core, the results of the DFCI sites (determination study) were just recently unblinded showing a significant
benefit of HDT even with maintenance till progression. With the help of this Core, the new proposal for clinical
study was developed in this renewal application to address how MRD status can inform the therapeutic approach.
The proposal is to perform a randomized phase III study comparing HDT versus additional cycles of induction
therapy for MRD negative patients and single versus tandem HDT for MRD positive patients. Moreover along
with clinical information a large amount of genomic and epigenomic data has been generated using the patients
samples that requires integrated analysis. In the prior funding period the Core has supported all the projects with
planning, analysis and integration. In this proposal Core will continue to support this effort and will provide 1)
support and direction on the formatting, quality control and annotation procedures of clinical and research data
as well as the process of transferring the research data a data warehouse for integrative analysis, 2)
bioinformatics support for primary and integrative analysis of the high-throughput data and 3) biostatistics support
in terms of design and analysis for all projects. Core members will work closely with all project members as well
as Cores 1 and 2 with regard to quality control, specimen tracking and data transfer procedures as well as Cores
3 and 4 which will perform next generation sequencing for identifying genomic, epigenomic and transcriptomic
changes at bulk and single cell level. Bioinformatics and biostatistics support and analysis is not only required
for individual projects, but it is crucial for the integrative analysis from data across the projects and thus overall
success of the program.

Public health relevance
Project Narrative – Core 5 – Biostatistics and Bioinformatics Core Dana-Farber Cancer Institute This core will help analyze a large, randomized phase III study comparing two consolidation treatment schedules for MRD negative patients to determine the role of HDT and role of single versus tandem HDT for MRD positive patients to inform therapeutic approaches. The core will provide bioinformatic support to unravel and integrate the genomic changes to better understand disease biology, features predictive of progression and define those changes able to predict outcome and inform the development of novel therapeutics.